NanoWizard V Atomic Force Microscope for Biomedical Research

Project Abstract
Many of our users, in the Atomic Force Microscopy core facility at the University of Texas Health Science Center
in Houston (UTHealth), are transitioning to more complex experimental protocols in the nanomedical sciences.
We are seeking support to upgrade our current BioScope-2 microscope to a NanoWizard V Atomic Force
Microscope (AFM) from Bruker Nano, Inc., as a shared resource. This new system will replace a 17-year-old
outdated AFM controller. Our existing Bioscope-2 AFM (2006) is obsolete, with limited applications, and
incompatible with newer CPUs. It is aging, and frequently crashes during experiments acquiring unreliable data.
It has an increasing downtime and leads to loss of valuable samples, limiting our efficiency and capabilities. The
new state-of-the-art NanoWizard V will provide enhanced applications to satisfy the more challenging requests
of our users working in leading research. It will be managed using the well-established infrastructure already in
place at our AFM core, which has a continuous project flow. It will be available to all investigators at the Medical
Center in Houston, in the spirit of enhancing collaborative efforts in the health sciences. The institutions that this
new acquisition will be available to include the University of Texas Health Science Center at Houston, MD
Anderson Cancer Center, Baylor College of Medicine, Rice University, Methodist Research Institute, and the
University of Houston, among others. This proposal will directly impact the research programs of 11 investigators,
including 10 NIH-funded users. The S10 users represent faculty from six different departments within UTHealth
and from one other neighboring institution. The NanoWizard V is the leader in BioAFM mechanobiology. It has
emerged as a key platform for studying the structural and nanomechanical properties of living systems. With its
high pixel density mapping and imaging, we will achieve resolution previously unattainable. In the force
spectroscopy mode, forces versus distance curves are recorded and provide access to the sample elastic and
adhesive properties. It will resolve the large variations on topography and desire to evaluate regions over the
millimeter range, in tissues and multi-cellular models, which represents severe practical challenges for prior and
existing AFM designs. With the new tip scanning technology in the Nanowizard V, it is expected to significantly
advance our understanding of dynamic physiological processes. The NanoWizard V will facilitate and expand
on our present and future research goals in cancer research, neuronal dysfunction, vision loss, pulmonary
disorders, antibody-antigen interactions, the fabrication of nanoparticles for tissue-specific targeting,
cardiovascular diseases and other research projects described within this application.

Public health relevance
Project Narrative Atomic force microscopy (AFM) is making vital contributions towards understanding pathological disorders and the development of innovative therapeutic approaches by quantifying specific binding, adhesion forces and elasticity of living systems. We are seeking support for a Bruker NanoWizard V AFM to sustain many ongoing and planned projects at UTHealth, Baylor College of Medicine, MD Anderson and other laboratories at the Texas Medical Center in Houston, with direct impact on biomedical research. With the acquisition of this new system, we will be able to assess the systemic response to biological processes such as growth, differentiation, disease and/or treatment by measuring changes in biomolecules, cells and tissues, and visualizing the nano-structural changes taking place at the molecular level.